Exosome Based Placental Maternal Communication

PROJECT SUMMARY/ABSTRACT
Pregnancy is a unique period in which the inherent biological complexity of any single human organism is
exponentially amplified by an intimate interaction between a rapidly developing fetus and an adult mother who
exhibits remarkable physiological adaptations over the nine months of pregnancy. Importantly, the biological
interests of the two organisms are not always congruent, reflecting conflicting metabolic interests and limited
supplies. Furthermore, maternal-fetal interaction does not occur through a passive sieve, but is actively and
dynamically orchestrated by the placenta, an organ with its own set of physiological needs. It is therefore
apparent that any disruption of the homeostatic equilibrium among the mother, placenta, fetus or their
environment may manifest as a clinical disease that challenges maternal physiology (e.g., preeclampsia) or
fetal development (e.g., fetal growth restriction), or may lead to premature termination of the pregnancy (e.g.,
preterm birth). The intact function of the placenta includes a set of signals that are generated by placental
trophoblasts and communicated to the maternal and/or the fetal compartments. These signals include
hormones (proteins, glycoproteins, steroid hormones) and growth factors, which have a paracrine and
endocrine effect on maternal and, possibly, fetal tissues. Our new line of research centers on nanovesicle
(exosome)-based communication. These exosomes are produced in human trophoblasts and harbor signals
that are germane to pregnancy health. Among these signals are placenta-specific microRNAs (miRNAs) that,
we recently showed, confer viral resistance to recipient cells. These miRNAs may also impact local placental
biological processes, such as trophoblast migration and invasion. While the placenta produces an abundant
number of exosomes, their target tissues are currently unknown. Moreover, the mechanisms by which
placental exosomes deliver their cargo to target cells and the regulation of their intracellular function have not
been hitherto investigated. We therefore seek to test the hypothesis that human trophoblastic exosomes use
specific uptake mechanisms to target maternal tissues, locally and distantly, and impact cell function. We will
test our hypothesis using human trophoblasts and exosomes derived from pregnant women. For those
experiments that cannot be performed in humans, we will use mice that have been validated as appropriately
modeling the human processes under study. Ultimately, our data will illuminate previously unknown
mechanisms of crucial, exosome-based communication between the feto-placental and maternal
compartments. Further, as placental exosomes are accessible via the blood, data generated by our
investigation will introduce new means to investigate the human placenta, and may promote the use of
exosomes as part of the diagnostics of placental dysfunction and indicate new avenues for nanoparticle-based
therapeutics.

Public health relevance
PROJECT NARRATIVE The placenta plays a critical role in fetal development and pregnancy health. We plan to study novel, nanovesicle-based communication pathways between placental and maternal tissues. These nanovesicles carry unique genomic signals to target cells, and may also participate in the protection of placental and maternal tissues against viral infections during pregnancy.